Colonoscopy in young onset colorectal cancer

NOTE: the below is unchanged from the original application.
PROJECT SUMMARY
Colorectal cancer (CRC) accounts for 8% of cancer incidence and 8% of cancer-related mortality in the
United States. While CRC risk and CRC-related mortality overall have decreased in recent years, the
proportion of CRC cases among adults ages <50—known as young onset colorectal cancer (YCRC)—has
increased. One clinical strategy recommended to detect YCRC earlier is colonoscopy for adults presenting
with conditions that might increase YCRC risk, such as iron deficiency anemia (IDA) or hematochezia (visible
blood in stool). Colonoscopy in these cases is conducted rule out CRC and has been proven to be particularly
effective among elderly adults. However, little evidence exists about the relative benefit among adults ages
<50. In light of increased YCRC incidence, a second clinical strategy recommended by the American Cancer
Society involves lowering the age of CRC screening initiation from 50 to 45, despite a paucity of evidence that
early screening initiation improves CRC-related outcomes in adults ages <50. While previous guidelines
advised CRC screening prior to age 50 only among adults with reported family history of CRC, this represents
only 30% of all CRC cases, meaning that identification of adults ages <50 most likely to benefit from YCRC-
related colonoscopy remains unclear. Furthermore, there are no imminent RCTs offering interventions like
colonoscopy for work-up of CRC-related conditions or screening asymptomatic adults, highlighting an urgent
need to learn about YCRC-related colonoscopy benefit among adults ages <50. Our study will use national
electronic health records and claims-based data from the Veterans Affairs (VA) Corporate Data Warehouse
(CDW) to address key gaps in the literature by evaluating these two clinical strategies for colonoscopy uptake
to address YCRC incidence and mortality. First, we will examine the benefits of colonoscopy uptake among
Veterans ages <50 with conditions (IDA or hematochezia) that may increase CRC risk by comparing CRC risk
among adults exposed to IDA or hematochezia (Aim 1a), examining proportion of timely colonoscopy uptake
≤60 days of IDA or hematochezia identification (Aim 1b), and comparing YCRC incidence, stage at detection
and mortality by colonoscopy uptake among Veterans with IDA or hematochezia (Aim 1c). Next, we will
compare the impact of exposure to colonoscopy on YCRC benefits among all Veterans ages 18-49 (Aim 2).
Our study will be the most comprehensive examination of early exposure to colonoscopy in the US to date and
will have important implications on current clinical guidelines and contextualize current CRC screening policy.
Major strengths include: (1) use of EHR and claims-based data from the largest integrated healthcare system
in the US; (2) VA studies have played critical roles in US clinical practice changes; and (3) the largest
assessment of colonoscopy uptake among adults ages <50 to date. Finally, this study offers a high-quality
postdoctoral training opportunity to understand current methods of CRC detection using colonoscopy, and to
develop key skills in cancer epidemiology and biostatistics to become a qualified independent investigator.

Public health relevance
NOTE: the below is unchanged from the original application. PROJECT NARRATIVE While young onset colorectal cancer (YCRC) incidence has been increasing over the last 10 years, it is unclear who will most likely benefit from earlier uptake of colonoscopy to reduce YCRC risk. Two clinical colonoscopy strategies are being recommended for adults ages <50 to address rising YCRC incidence and mortality: 1) colonoscopy for conditions that may increase YCRC risk (iron deficiency anemia and blood in stool) to rule out YCRC; and 2) earlier initiation of CRC screening at age 45 instead of age 50; evidence to support effectiveness of these strategies is limited. The proposed study intends to address these evidence gaps by reviewing the efficacy of these two methods, highlighting the potential YCRC-related benefit of colonoscopy uptake among Veterans ages <50.